SOFTWARE DISTRIBUTED BY THE MACCOSS AND NOBLE LABS, 2008-2009

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Noble and Maccoss Labs distributed the following software in 2007-2008: BiblioSpec: A suite of programs for creating, filtering, and searching MS/MS spectrum libraries ChargeCzar: uses a support vector machine to discriminate between +2- and +3-charged tandem mass spectra, with the goal of reducing database search time by eliminating the need to search twice with each spectrum. Crux analyzes shotgun proteomics tandem mass spectra, associating peptides with observed spectra. Percolator post-processes the results of a shotgun proteomics database search program, re-ranking peptide-spectrum matches so that the top of the list is enriched for correct matches.